Host-bacterial interactions determining the spectrum of Mtb transmission

Halting tuberculosis (TB) transmission by active case finding is challenging, requires substantial resources and is unaffordable in many countries with a high burden of TB. Host-directed therapeutics or prevention of infection (POI) vaccines that prevent Mycobacterium tuberculosis (Mtb) from establishing infection in exposed contacts could be potentially powerful tools to break the transmission cycle of Mtb and accelerate TB elimination. Significant gaps exist in our understanding of the biology of the spectrum of Mtb infection in exposed contacts. A household contact (HHC) study conducted by our group found that the transmissibility of Mtb from the index case was heterogenous using Interferon-Gamma Release Assay (IGRA) and tuberculin skin test (TST) positivity to infer infection. Households (HH) were categorized into High (HT), and Low (LT) transmission groups based on the proportion of HH contacts (HHC) with a positive (IGRA) and/or TST. Mtb strains from index cases of the HT and LT households were designated Mtb-HT and Mtb-LT, respectively. In susceptible mice, Mtb-HT and Mtb-LT strains induced distinct in vivo immunopathological responses. Furthermore, Mtb-HT and Mtb-LT strains induced distinct metabolic reprogramming of THP1 cells (preliminary data). Individuals who remain IGRA negative despite long-term and intense exposure to Mtb, are considered to have either resisted infection or cleared it and are referred to as ‘resisters’. Several immune mechanisms have been associated with resister phenotype, including responses mediated by macrophages, T cells and B cells. In preliminary studies, we found that a significant proportion of IGRA- HHCs were from LT-HH and had evidence of non-canonical antigen-specific T cell (NCAT) activation (measured as increased expression of activation markers) that was interferon (IFN) independent. This suggests that the current binary classification of exposed contacts as IGRA+ or IGRA- does not capture the complexity of the Mtb infection spectrum. Moreover, NCAT activation in IGRA- may be a protective phenotype as most TB arises from IGRA+ individuals. Epidemiological studies have shown a substantial association between human genetic variations and bacterial genotypes and the development of TB. Our overarching hypothesis is that Mtb-HT and Mtb-LT strains are phenotypically and genetically diverse, and the contribution of this inter-strain variability is at least as consequential to infection outcome in exposed individuals as is the contribution of inter-individual variability. Findings from our study will provide insights into mechanisms that regulate resistance to Mtb infection. Identification of mechanisms of resistance may lead to novel approaches for immunomodulatory therapy targeting host macrophage anti-microbial pathways and identifying genomic signatures segregating Mtb-HT and Mtb-LT may provide novel Mtb targets for developing POI vaccines that induce T-cell responses that activate macrophages or “train” the innate immune system to eliminate Mtb.

Public health relevance
Recruitment: The study will be conducted at GTBI which provides outpatient services at a state-of-the art clinical facility in Newark, NJ and will focus on pulmonary tuberculosis (TB) index cases and their household contacts. GTBI provides oversight of over half of the total TB disease morbidity in New Jersey (top six in TB case count and TB incidence among US states in 2024) including in Essex, Union, Hudson, and Middlesex counties. These counties include Newark, NJ's largest city, Elizabeth, the third largest city and the major cities of East Orange, Irvington, Orange, Plainfield and Union. The clinic is a regional site for the NJ Department of Health to provide services in other counties that do not have the expertise in medically managing complicated cases. The Lattimore practice is also part of University Hospital in Newark, NJ, which will provide a referral basis of inpatient TB patients. These centers are the primary healthcare facilities for TB diagnosis, treatment, and monitoring, ensuring access to eligible participants who are household contacts of confirmed pulmonary TB cases. Patient care including monitoring of smear and culture results and sensitivities and contact investigation is delivered through a case management system. The target recruitment proposed in the application is n=150 TB cases and n=600 household contacts (HHCs). Index cases Index cases will be identified and enrolled through the three Regional Tuberculosis Clinics (RTBCs) in New Jersey (Lattimore Practice, Middlesex County Public Health Clinic, and Hudson County Chest Clinic). At these clinics, we see 215 active TB (ATB) and 720 HHCs patients. To achieve the study's target of 150 index cases for follow-up, we will screen 300 pulmonary TB index cases across the three centers. The following are the inclusion criteria: 1) age ≥18 years with cough ≥3 months; 2) signs and symptoms consistent with TB; 3) new TB episode with at least 2 positive sputum smears for acid-fast bacilli or at least one positive Xpert MTB/RIF with medium/high semiquantitative results; 4) a positive MGIT culture from sputum; 5) living with at least 4 household contacts. Household Contacts We will enroll 600 household contacts of the enrolled index cases. A household contact will be defined as an individual of any age fulfilling at least one of the following criteria of close contact with the index TB cases for ≥3 months before enrollment: 1) sleeping under the same roof ≥5 days/week; 2) sharing meals ≥5 days/week; 3) watching TV nights or weekends, and; 4) other significant contact (85% of these visited the household >18 days/month). Household contacts must be genetically related to the index case. We will not enroll pregnant women. Retention Study staff will update contact information at the time of enrollment. Incentives and enablers will be used to assist participants. Typically, this involves a combination of transportation voucher and food voucher. Inclusion Enrollment Report IER ID# Enrollment Location Type Enrollment Location IER1 Domestic Middlesex County Public Clinic. Address: 35 Kennedy Blvd, East Brunswick, NJ 08816 Hudson County Chest Clinic. Address: 257 Cornelison Avenue Jersey City, NJ 07302 Lattimore Clinic. Address: 225 Warren Street Newark, NJ 07101